Creation of a technology-ready cohort for patients with Alzheimer's disease and related dementias and their caregivers

Project Summary
Traditionally, Alzheimer’s Disease and related dementias (ADRD) patients are evaluated
infrequently, imprecisely, and in artificial settings. This creates significant barriers to monitoring
disease progression and caregiver burden in ADRD, and to assessing the impact of clinical and
investigational interventions.
Digital assessment measures— including digital phenotyping and artificial intelligence (AI)
assessments and machine learning algorithms— can provide more reliable, more naturalistic (i.e.,
in a patient’s home environment) and more frequent (e.g., continuous) measurements in ADRD
patients than those used in clinical settings. These assessments may also monitor safety more
accurately, assure medication adherence, and facilitate communication with a patient’s medical
team. Moreover, because of the enhanced sensitivity of these measures, they may better predict
conversion to dementia in preclinical individuals. However, there are barriers to implementing
these digital technologies. These include understanding which technologies can be most readily
used in older— and not necessarily tech-savvy— populations, understanding the barriers to the
adoption of these technologies in these populations, and confirming that these technologies
provide tractable and predictive data regarding cognitive and behavioral disease progression. To
address this, this proposal will create and train a “technology-ready cohort” upon which digital
assessments relevant to ADRD patients and their caregivers can be tested. Next, we will show
that these assessments better predict key cognitive and behavioral outcome measures in ADRD
than standard clinical or research visits. In parallel, we will iteratively evaluate and address
barriers to the adoption of these technologies in these populations.

Public health relevance
Project Narrative There is a significant need to better monitor and support ADRD patients and their caregivers. While clinical visits address these issues, these occur infrequently, and the measures employed lack ecological validity. There is strong interest in using digital technology and artificial intelligence (AI) to monitor patients in their home environments, and at much greater frequency than in clinical settings.